Actions of proline at receptors and synapses

Disturbances in brain handling of the amino acid proline are linked to a wide variety neurological and
behavioral disorders including schizophrenia, autism, epilepsy, intellectual disability, and depression. Although
proline has been suggested to be a candidate neurotransmitter, a demonstration of a prolinergic component of
synaptic has been lacking. Proline is thought to mediate its action, in part, via activation of ionotropic glutamate
receptors, which mediate the majority of synaptic transmission in the central nervous system. Yet, the actions of
proline at glutamate receptors and synaptic transmission are not well understood. We hypothesize that the
proline sensitivity of ionotropic glutamate receptors varies with subunit composition. Moreover, we propose that
prolinergic transmission can be demonstrated by pharmacologically probing transmission between neurons that
express SLC6A7, the high-affinity proline transporter responsible for a majority of synaptic proline uptake, and
its postsynaptic partners. We will use a combination of electrophysiological, molecular, immunocytochemical,
and imaging methods we will examine: 1) the pharmacological profile of proline at recombinant ionotropic
glutamate receptors with distinct subunit compositions; 2) the preferred hippocampal cell types that are targets
of putative prolinergic neurons; and 3) the how synaptically evoked proline accumulations shape glutamatergic
transmission. Collectively, these studies will fill in major gaps in our knowledge regarding the actions of proline
at glutamate receptors and synapses where prolinergic transmission likely occurs.

Public health relevance
Alterations in proteins that control brain levels of the amino acid proline are risk factors for multiple neurologic and behavioral disturbances including schizophrenia, autism, intellectual disability, epilepsy, and depression. We will examine the actions of proline at glutamate receptors and the relevance of these actions towards neuronal transmission. These studies will enable us to understand how disturbances in proline handling alter synaptic transmission and contribute to these disorders, which is essential for developing new treatment strategies.